Increased CNS Opioid Exposure by an Acetaminophen-Induced Blood-Brain Barrier Mechanism

PROJECT SUMMARY
Over the past several years, we have studied changes in critical blood-brain barrier (BBB) tight junction
(TJ) proteins (i.e., claudin-5, occludin) in response to diseases or drugs. Our work has shown that claudin-5 and
occludin expression and trafficking is modulated by pain (i.e., TJ dysregulation), an effect that increases brain
uptake of opioids such as codeine. Our preliminary data show that acetaminophen (APAP) can modulate
expression of claudin-5 at the BBB and increase paracellular permeability (i.e., “leak”). Leak has previously been
shown to occur with low dose, acute cocaine administration as well as methamphetamine. Both APAP and pain
target transforming growth factor- β (TGF-β) signaling, a pathway that controls TJ expression and BBB integrity.
In this grant, we hypothesize that APAP, by itself and in the setting of pain, can increase BBB
“leak” and enhance CNS opioid delivery. These studies are highly significant because they will uncover
mechanisms of altered opioid antinociception and adverse drug events that can occur in individuals
who abuse or misuse opioids or APAP. Additionally, APAP is taken with other centrally acting drugs
where “APAP leak” can lead to therapeutic toxicity.
Aim 1: To investigate, in vivo, changes in TJ protein expression and trafficking at the BBB
following APAP administration. We will study how APAP alters CNS effects and adverse events of opioids.
We will investigate the time course of changes in transmembrane TJ protein (i.e., claudin-5, occludin) expression
and trafficking and the dose-response relationship of APAP on changes in TJ protein complexes in male and
female Sprague-Dawley rats (Aim 1A). We will then study the temporal relationship between CNS opioid
delivery, opioid-associated antinociception, respiratory depression, and opioid-associated reward behavior (Aim
1B). Since we have shown that transforming growth factor- β (TGF-β) signaling regulates BBB integrity, we will
study the role of this pathway on claudin-5 and occludin expression and trafficking (Aim 1C).
Aim 2: To examine involvement of APAP on BBB integrity in pain. Using established in vivo pain
models (i.e., l-carrageenan-induced acute inflammatory pain, chronic pain spinal nerve ligation), we will study
the time course of APAP effects on TJ protein expression/trafficking (i.e., claudin-5, occludin) as well as on CNS
opioid uptake (Aim 2A). We will demonstrate effects of single versus multiple doses of APAP on TGF-β signaling
pathways in both pain models (Aim 2B). We will study how changes in CNS opioid delivery affect opioid
antinociception, respiratory depression, and opioid-associated reward behavior (Aim 2C). Since we have shown
that APAP increases functional expression of the critical opioid transporter P-glycoprotein, we will examine the
contribution of claudin-5/occludin modulation and P-gp changes to CNS opioid delivery (Aim 2D).
Our group is uniquely positioned to provide a mechanistic explanation (i.e., signaling, activity,
trafficking) for adverse drug events in individuals who abuse/misuse prescription pain drugs.

Public health relevance
PROJECT NARRATIVE Acetaminophen (APAP) and analgesic products comprised of APAP and opioids are frequently abused and misused, a characteristic of the current prescription drug problem in the United States. Novel data from our laboratory has shown that APAP can alter expression of blood-brain barrier (BBB) tight junction proteins complexes and lead to paracellular “leak.” This grant proposal will study BBB changes in critical TJ proteins (i.e., claudin-5, occludin) expression and trafficking induced by APAP (both by itself and in in vivo models of acute/chronic pain), work that will directly impact public health in the United States by uncovering mechanisms of adverse drug events that can occur in individuals who abuse or misuse APAP and/or pharmaceutical products containing APAP.